Mechanistic underpinnings of trigeminal nerve stimulation as a therapeutic approach to TBI

Project Summary/Abstract
Traumatic brain injury (TBI) is a leading cause of death and disability, and is associated with elevated risk of
chronic health conditions including dementia. Cerebral edema is a particularly deleterious complication of TBI
which greatly increases risk of death, but current clinical approaches for edema management do not lead to signif-
icant improvements in patient outcomes. Recent translational studies of TBI in mice demonstrate that trigeminal
nerve stimulation (TNS) offers a low-risk, noninvasive therapeutic approach that reduces edema and improves
functional outcomes. However, stimulation parameters vary widely across studies, and the mechanisms of edema
reduction are not well-understood. The research proposed herein seeks to utilize both mouse experiments and
realistic numerical simulations to probe stimulation parameter sensitivity and obtain a mechanistic understanding
of how nerve stimulation leads to edema reduction. Such insights are necessary for rapid and effective trans-
lation of TNS-based therapies, and indeed, results from this research will help inform upcoming TNS studies in
humans. The central hypothesis of this proposal is that TNS improves functional outcomes after TBI by enhanc-
ing extracellular ﬂuid transport through the glymphatic system (a pathway in which cerebrospinal ﬂuid exchanges
with interstitial ﬂuid in the brain). Four lines of evidence support this hypothesis: (1) a recent Nature publica-
tion demonstrates that restoring disrupted glymphatic transport following TBI removes excess ﬂuid and cortical
debris, sharply reducing neuroinﬂammation and improving functional outcomes; (2) glymphatic ﬂow is driven by
arterial pulsations, and prior TNS studies use pulsed stimulation that enhances arterial pulsatility; (3) prior work
shows that stimulation of the vagus nerve enhances glymphatic transport; and (4) multiple studies show analo-
gous sensory (e.g., whisker) stimulation alters cortical blood ﬂow and enhances glymphatic transport. Speciﬁc
Aim 1 will test the central hypothesis by measuring brain-wide glymphatic inﬂux due to variable TNS parameters
(stimulation frequency, intensity, duty cycle) and will yield a near-optimal parameter set corresponding to maxi-
mum glymphatic transport. Speciﬁc Aim 2 will provide the ﬁrst high-resolution, in vivo quantiﬁcation of changes in
arterial diameter and glymphatic transport during TNS. This will be achieved using two-photon microscopy while
TNS is administered with near-optimal parameters. Speciﬁc Aim 3 will leverage an existing, versatile simulation
of the murine glymphatic system to causally establish the extent to which increased arterial pulsatility enhances
glymphatic transport. Results from this study will: (1) conclusively demonstrate whether TNS ameliorates acute
post-TBI edema via enhanced glymphatic transport, (2) yield a set of near-optimal TNS parameters, (3) directly
quantify TNS-induced alterations to blood/glymphatic ﬂow, and (4) quantify the extent to which increased glym-
phatic transport due to sensory/nerve stimulation may be attributed to increased arterial pulsatility. Importantly,
this study will have direct translational value: research results will help guide upcoming human studies in which
TNS will be administered to humans using a noninvasive, wearable device with potential for commercialization.

Public health relevance
Project Narrative Traumatic brain injury (TBI) is a signiﬁcant cause of death and disability, but the effectiveness of clinical treatments is limited. Recent studies indicate that electrical stimulation of facial nerves following TBI can reduce brain injury, but the underlying mechanisms are not understood. We will perform mouse experiments and numerical simulations to investigate the underlying mechanisms to help translate this novel therapy to humans.